Project 3 - Modulation of Antiviral Immunity and T cell Exhaustion by Inhibitory Receptors

SUMMARY
Despite considerable clinical impact of blocking checkpoints such as PD1 and LAG3, the mechanisms remain
poorly understood. One remaining gap is how PD1 and LAG3 regulate formation of TEX precursors early in
chronic infection and mature TEX subsets later. Answering this question will identify molecular mechanisms that
link PD1 and LAG3 to preventing or reversing exhaustion and new therapeutic opportunities. We hypothesize
that individual and combined signals from PD1 and LAG3 engage temporally distinct, therapeutically relevant
mechanisms to regulate T cell exhaustion that will be discovered by dissecting the synergy between these
pathways at different stages of T cell exhaustion. This project will address this hypothesis by testing:
Aim 1: How do signals from PD1 or LAG3 or both promote formation of TEX precursors? Here, we will
reveal how PD1 and/or LAG3 are involved in initial molecular and cellular establishment of early TEX formation
and provide opportunities for preventing development of exhaustion. We hypothesize that PD1 and/or LAG3 are
necessary to initiate and temporally reinforce development of TEX during chronic viral infection through
mechanisms that involve TCF1, NFAT, and/or TOX. We will use constitutive or inducible CD8 T cell-intrinsic PD1
and/or LAG3 deficiency together with antibody (Ab) blockade and novel exhaustion tracking mice
(i.e.Lag3CreERT2.Rosa26LSL.tdTomato or ToxCreERT2.Rosa26LSL.tdTomato) from Core B. Thus, Aim 1 will deliver detailed
maps of how PD1 and LAG3 separately and together regulate initial formation of TEX.
Aim 2: What are the molecular and epigenetic events caused by temporally induced loss of PD1 or LAG3
in mature TEX subsets? Despite the clinical relevance of checkpoint blockade, the underlying biology of TEX
reinvigoration remains poorly understood, particularly surrounding early molecular events associated with
reinvigoration in vivo and its impact on different TEX subsets. We hypothesize that early molecular events
following removal of PD1 and/or LAG3 are distinct for different TEX subsets, imparting novel functional,
transcriptional, and/or differentiation changes that will enable us to identify new molecular targets to reverse or
prevent exhaustion. Here, we will interrogate bulk and single-cell transcriptional as well as epigenetic changes
in total TEX and TEX subsets over a high-resolution time-course following removal of PD1 and/or LAG3.
Discoveries will be further dissected using in vivo CRISPR/Cas9 screening and RV approaches (Core C). These
data will provide important insights for applying PD1 and/or LAG3 blockade in humans.
PPG Interactions: Because the core program of exhaustion is conserved in chronic infections, tumors, and
autoimmunity, Project 3 will connect extensively with Projects 1 and 2 for experimental models and mechanistic
insights from autoimmunity or tumors. We will also coordinate with Core A to exchange data and interact, Core
B to obtain mice, Core C for RV approaches and bioinformatics, and Core D for immunohistology.

Public health relevance
Project Narrative Chronic infections with viruses such as HIV, HCV and HBV affect half a billion people and are significant causes of morbidity and mortality. T cell dysfunction or “exhaustion” is a major immunological defect during these infections and can be modeled with LCMV infection in mice. The studies proposed will define the role of the inhibitory receptors PD1 and LAG3 in CD8+ T cell exhaustion and provide new insights into how to reverse and avoid T cell exhaustion and improve immunity during these and other chronic infections.